The Tisch Cancer Institute - Cancer Center Support Grant

The mission of the Tisch Cancer Institute is to accelerate the prevention and treatment of cancer, improving the lives of cancer patients and their families in our community. Guiding our mission, are the TCI principles of discovery, translation, education, enhanced access, and engagement. To accomplish this mission, the TCI has developed collaborative research programs that strive to translate discoveries to new therapies and to develop new prevention and delivery strategies with priority given to cancers affecting our catchment area. TCI’s four cancer research programs are: Cancer Immunology, Cancer Mechanisms, Cancer Prevention & Control, and Cancer Clinical Investigation. Within its four programs, the TCI has a strong foundation of cancer research with direct cancer-related funding of $ 67,799,054. This includes peer-reviewed funding of $ 50,197,871, of which $ 27,702,214 are from the NCI. The TCI fosters intra and inter-programmatic cancer research through strategic planning, pilot project awards, interdisciplinary meetings and retreats, and disease-specific focus groups. In addition, the TCI enables cutting-edge research by providing outstanding cores, equipment, facilities and information technology. TCI supports the following seven shared resources: Flow Cytometry, Microscopy & Advanced Imaging, Biostatistics, Human Immune Monitoring Center, Cancer Genomics Technologies, Biorepository & Pathology, Bioinformatics for Next Generation Sequencing. The cancer Clinical Research Services Unit with its Early Phase Trials Unit provides the infrastructure to conduct novel, investigator initiated protocols developed by TCI investigators. The TCI’s catchment area includes the five boroughs of New York City (NYC) with emphasis on areas experiencing excess cancer incidence, morbidity and mortality as compared to NYC and the US. The TCI is the coordinating center for the World Trade Center First Responders Program, and the rescue workers affected by the 9/11 attacks form a distinct and unique component of the TCI catchment area. The TCI also has components focused on education and training, outreach and engagement, to support its mission. TCI develops and fosters a dynamic team of scientists, clinical investigators and administrators and provides the research infrastructure support needed to spur new cancer discoveries and improve the outcomes of cancer patients and their families.

Public health relevance
The mission of the Tisch Cancer Institute is to accelerate the prevention and treatment of cancer, improving the lives of cancer patients and their families in our community. To accomplish this mission, the TCI has developed collaborative research programs that strive to translate discoveries into new therapies and to develop new prevention and delivery strategies with priority given to cancers affecting our catchment area.